RAND Postdoctoral Training Program in the Study of Aging Renewal

PROJECT ABSTRACT
Since 1994, the National Institute on Aging (NIA) has supported post-doctoral training for two
fellows per year as part of the RAND Postdoctoral Training Program in the Study of Aging. Here, we
are proposing that NIA extend funding for another five years in support of two fellows per year,
beginning in 2021.
RAND offers a rich and unique environment for advanced training in the study of aging; that
environment is characterized by a strong emphasis on interdisciplinary research and is supported by 9
Centers dedicated to the study of myriad issues of relevance to research in aging, a diverse and
distinguished group of scholars, strong mentoring capabilities, excellent facilities and strong research
support services, and the availability of formal instruction in various research skills. All told, 46
researchers will participate as part of the training faculty. We plan to recruit our two fellows from recent
Ph.D.s in demography, economics, gerontology, psychology, sociology, or other relevant disciplines
who are just completing their degree or who have a few years of experience. The fellows will pursue
programs of advanced research training in the field of aging for up to two years.
The postdoctoral program in aging at RAND offers highly individualized training to the fellows,
including on-the-job training in the study of aging issues and other training designed to enhance the
fellows' analytical and communication skills, and understanding of the responsible conduct of research.
Specifically, fellows can enroll in seminars in the Pardee RAND Graduate School (PRGS); participate in
courses offered by RAND's statistical, computing, survey, and communications experts; and attend
numerous seminars offered at RAND and neighboring universities. The Program Director, mentor, and
other training faculty and research support staff will help the fellows prepare research presentations for
professional meetings and papers for submission to journals. Fellows will also be encouraged to
develop a proposal for a research project (to be executed after completing their postdoctoral tenure) for
submission to a federal agency.

Public health relevance
PROJECT NARRATIVE The National Institute on Aging (NIA) has funded the RAND Postdoctoral Training Program in the Study of Aging over five five-year cycles. We propose five more years of support for two postdoctoral fellows per year, beginning in 2021. RAND offers a rich and unique environment for advanced training in the study of aging—one characterized by a strong emphasis on interdisciplinary research, supported by 9 Centers dedicated to the study of myriad issues of relevance to aging, a diverse and distinguished group of scholars and mentors, excellent facilities and strong research support services, and the availability of formal instruction in research skills that postdoctoral fellows will need to productively advance in their careers.